FUNCTIONAL CHARACTERIZATION OF THE PRDM10-ZN FINGER TRANSCRIPTION FACTOR IN EARLY MAMMALIAN DEVELOPMENT

SUMMARY
During embryonic development and lineage specification, a complex set of extracellular signals is integrated
on chromatin by Master Transcription Factors (TF) that modify chromatin structure and gene expression. PRDM
proteins are TFs, containing a PR-methyltransferase domain at their N-terminus and DNA-binding Zn-fingers at
their C-terminus. All 17 PRDM family members are well known for their role as master regulator of lineage
specification and their deregulated expression is often linked to diseases.
Our group has characterized the function of PRDM10, a transcriptional activator, orchestrating mouse
preimplantation development. Our preliminary data indicate that: 1) Prdm10 zygotic KO embryos have visible
defects at embryonic day E3.5; 2) Prdm10 maternal (Zona Pellucida3 (Zp3)-CRE) KO embryos arrest at the
zygote/two-cell stage; 3) PRDM10 is unique among PRDM family members, as it contains a Glutamine-rich
coactivator domain at its C-terminus. Based on this preliminary data we propose the following experiments:
In Aim1 we will determine the function of maternal PRDM10. We will take advantage of the Zp3-CRE
strain, to delete Prdm10 in the oocyte, and deplete the PRDM10 maternal protein contribution in the zygote. This
will allow us to study the function of PRDM10 before zygotic transcriptional activation and determine the gene
network directly regulated by PRDM10.
In Aim2 we will determine the mechanism of action of PRDM10 as a transcription factor. In this aim we
will characterize the mode of action of PRDM10 (i.e. its methyltransferase activity, its protein interactome, and
its transcriptional activation and DNA binding-properties). We will also specifically address PRDM10’s function
in dictating the choice of alternative promoter usage. Finally, we will validate the function in oocyte and early
embryogenesis of key PRDM10-downstream effectors.
The significance of these studies is that Prdm10 is an uncharacterized maternal effect gene, and knowledge
of the pathways regulated by this Zn-finger TF will be useful to the field of stem cell biology and reproductive
medicine.

Public health relevance
NARRATIVE Recent work from our group has demonstrated that PRDM10, a member of the PRDM family of transcription factors, is essential in early embryogenesis leading to developmental arrest, and defects in the translation machinery. Given the expression of PRDM10 in the oocyte and its essential function as a maternal-effect gene, here we propose to investigate the function, at the mechanistic level, of PRDM10 at early stages of mammalian development. This work will greatly expand our knowledge on basic developmental processes and on the epigenetic, transcriptional and translational regulation of early embryogenesis, with future implications for reproductive biology.